Optimizing Gram-positive bacteria as a candidate for targeted anti-tumor therapy

PROJECT SUMMARY/ABSTRACT
Cancer is the second leading cause of death globally and many available treatments lack the safety and effica-
cy sought by oncologists and patients alike. Major efforts have been made to use living organisms, such as
bacteria, as vehicles to produce and deliver site-specific therapeutic payloads, however they are mostly cen-
tered on Gram-negative bacteria. In this proposal, we aim to expand the list of candidates available for probi-
otic cancer therapy by exploring the potential for species of Bacillus to colonize tumor microenvironments.
Many Bacillus species are generally regarded as safe (GRAS) and as Gram-positives are capable of high pro-
tein product secretion. Therefore, we will also aim to expand the genetic toolbox for model organism, Bacillus
subtilis, in order to develop Gram-positive production hubs of anticancer therapies. Using the bacteria-in-
spheroid coculture (BSCC) model, we can rapidly screen for optimal isolates and recombinant protein products
and use in vivo mouse models for follow up experiments exploring only the high preforming candidate strains.
With in vitro and in vivo approaches, we aim to develop novel, safe, and effective alternatives to treat tumor
growth and increase the quality of cancer therapy.

Public health relevance
PROJECT NARRATIVE Scientists are still searching for safe and affective alternative cancer treatment regimens, and thus modern ad- vances in research have shifted the focus to synthetic biology as a tool to innovate medical research. Using the mechanisms endogenous to bacteria, we can harness their natural capabilities of localization, division, produc- tion, and secretion to engineer biologic therapeutic alternatives. Our focus on Gram-positive bacteria will allow us to expand the synthetic biology toolbox and identify novel organisms ideal for targeted cancer therapies.